Investigating the Role of Thyroid Hormone in Placental Function

Investigating the Role of Thyroid Hormone in Placental Function
Thyroid hormone (TH) is necessary to support both fetal and placental development during pregnancy.
Maternal supply of TH to the fetus early in pregnancy is necessary before the fetus can produce TH itself,
which starts around 16 weeks of gestation with significant TH secretion not occurring until 18-20 weeks. The
placenta uses thyroid hormone to regulate metabolic processes, which includes using 60-80% of the oxygen
and glucose it takes up from the maternal circulation. Impaired placental development and function is an
underlying cause of fetal growth restriction (FGR), which is a significant cause of infant morbidity and mortality.
The causation and progression of placental insufficiency is not well understood and requires studies that
investigate the mechanisms of placental function. It is difficult to directly address these questions in humans,
predicating the need for relevant animal models. Regulation of placental function by thyroid hormone during
pregnancy is complex with the potential to regulate proliferation, differentiation, hormone production, invasion
and angiogenesis. Major gaps exist in our understanding of how T3 and T4 are used by the placenta to regulate
placenta metabolism and function, and further how the placenta regulates transport of T4 through the placenta
to fetal circulation. TH function by the placenta is regulated by iodothyronine deiodinase type II (DIO2) which
converts T4 to active T3, supporting placental growth and oxidative processes. Iodothyronine deiodinase type III
(DIO3) converts T4 to an inactive form, reverse T3 (rT3). DIO3 will both inactivate TH within the placenta and
limit the amount of T4 that can pass through the placenta to the fetus, however, this has not been tested in
vivo. Clearly the uptake, transport and activity of TH within the placenta is complex, and needs clarification,
especially during the first half of gestation when the placenta is rapidly developing, and the fetus is dependent
on maternal derived TH. It is our long-term goal to determine the causes behind impaired placental function,
and how placental-insufficiency manifests itself in FGR. Historically, the pregnant sheep has provided
considerable insight into in vivo placental substrate uptake, utilization and transfer to the developing fetus.
Herein, we will test our central hypothesis that impairment of trophoblast expression of either DIO2 or DIO3 will
result in significant placental and fetal growth restriction by mid-gestation, setting the stage for functional
placental insufficiency (PI) and FGR. In aim 1 we will test the hypothesis that DIO2 deficiency will result in
impaired placental development and significant FGR by mid-gestation (75 dGA). In aim 2 we will test the
hypothesis that DIO3 gain-of-function will result in decreased placental transport of T4 across the
placenta to the fetus, a hypothyroid fetus and significant FGR by mid-gestation (75 dGA). Use of
lentiviral mediated RNA interference of DIO2 and gain-of-function of DIO3 will test our central hypothesis and
provide a unique animal model to assess the in vivo physiological function of placental thyroid hormone.

Public health relevance
Narrative / Public Health Relevance Statement Functional placental insufficiency is a major cause of fetal growth restriction, leading to infant morbidity and mortality. In this proposal, we will use a novel approach to investigate the significance of the two regulators of thyroid hormone function, DIO2 and DIO3 during the first half of gestation. This work will provide insight into the mechanism and relative importance of these thyroid hormone regulators in the placenta and will lay the groundwork for extensive in vivo investigations into placental thyroid hormone utilization and transport to the fetus, and enhance our understanding of how functional placental insufficiency results in pregnancy complications.